Role of Sphingolipid pathways in the pathobiology of PAH

ABSTRACT
Pulmonary arterial hypertension (PAH), a rare, debilitating and fatal disease for which there is currently no
available cure. There is compelling evidence that the Sphingosine kinase1/S1P signaling axis is a novel and
therapeutic target for PAH. To facilitate the translation of current in vivo and in vitro observations on the role
of S1P dependent signaling in PAH pathobiology, this proposal will explore the hypothesis that the Sphingosine
kinase1/S1P signaling axis regulates physiologic, cellular and molecular pathways in PAH that result in
pulmonary vascular remodeling. SA1 seeks to define the role of LncRNA Khps1 in miR-1 and SPHK1 expression
and promoting pulmonary vascular remodeling. SA2 seeks to define molecular mechanisms by which LncRNA
Khps1/SPHK1 regulate pulmonary artery smooth muscle cell mitochondrial dynamics. SA3 will investigate the
role of SPHK1 in aberrant chromatin remodeling and gene expression in the development of pulmonary vascular
remodeling.

Public health relevance
PROJECT NARRATIVE This project will investigate the role of Sphk1/S1P dependent pathways in the development of pulmonary hypertension, an incurable disease associated with high mortality.